Epstein-Barr Virus/Kaposi Sarcoma Associated Herpesvirus 2024 Meeting

ABSTRACT
This conference grant application requests funds to help support the 2024 International Conference on EBV &
KSHV. The conference will be held at the Boston Park Plaza Hotel. This joint conference is unique and
innovative in that it combines the International Workshop on Kaposi’s Sarcoma-Associated Herpesvirus
(KSHV) and Related Agents and the International Symposium on Epstein-Barr Virus (EBV) and Associated
Diseases. The funds will be used to reduce the conference registration costs for outstanding pre- and post-
doctoral trainees, historically under-represented minorities including those from underserved areas. The goals
of these meetings are consistent with the mission statements of the NIH, NCI, NIAID, and NIDCR, namely, to
advance and promote the pace of research on infections associated with human cancer and other diseases,
including in the setting of HIV-AIDS. The joint EBV & KSHV Meeting will be held June 29th – July 3rd, 2024. All
remaining costs for these conferences will be raised from registration fees paid by the conferees and
contributions, foundations, and pharmaceutical and biotechnology companies. The main focus of the EBV &
KSHV meeting is on the biology of oncogenic herpesviruses and associated human diseases, with specific
emphasis on viral pathogenesis, viral latency and reactivation, viral gene expression and replication, host
responses to infection and autoimmunity, epidemiology, vaccine development, and therapeutic intervention. In
addition to EBV and KSHV, studies related to Herpesvirus saimiri, murine herpesvirus-68, rhesus rhadinovirus,
and rhesus lymphocryptovirus will be presented. The combined EBV/KSHV conference has not been held
since 2018 and will optimize the potential for synergistic interactions among the conferees and the potential for
new collaborations.

Public health relevance
Narrative Most adults worldwide are infected by EBV and KSHV. These viruses play complex co-factor roles in a variety of malignancies, including Burkitt, Hodgkin, post-transplant, T/NK and pleural effusion lymphoma, multicentric Castleman’s disease, Kaposi’s sarcoma, nasopharyngeal and gastric carcinoma. This conference will discuss recent advances in the KSHV and EBV fields, including host/virus interactions, immune responses to EBV/KSHV and opportunities for novel vaccine and therapeutic approaches.